Center for Structure of Membrane Proteins

DESCRIPTION (provided by applicant): Integral membrane proteins account for ~30% of a proteome and play critical roles in metabolic, regulatory and intercellular processes. Human MPs are the targets for ~40% of all therapeutic drugs, but the number of MP structures is less than 0.5% of the number of soluble protein structures. The proposed Center brings together 11 Investigators at five US institutions to focus cooperatively on the overarching aim of determining integral MP structures of high biomedical impact. The Specific Aims balance multiple priorities. Aims 1-3 are extensive, seeking to obtain structures by providing many targets from (1) E. coli, (2) extremophiles, and (3) human. The broad target base is triaged by dynamic bioinformatics screening to direct focus on the most tractable set by the end of year 1. Aims 4 and 5 are intensive, targeting families of highest biomedical relevance and impact for which structures have generally not yet been obtained;Aim 4 concerns specific prokaryotic MPs;Aim 5 involves the most challenging eukaryotic MPs, including human therapeutic targets and components of the nuclear pore complex. Aim 6 leverages MP structures by comparative modeling developed specifically for MPs. Ten core capabilities implement the methods that support the aims and cover every aspect of structure determination, including target selection, cloning, expression, purification, crystallization, structure determination by X-ray crystallography, NMR spectroscopy or electron microscopy, and modeling. The cores provide multi-point entry to High-Throughput-Enabled Structural Biology Partnerships. Expression cores cover prokaryotic and eukaryotic (including HEKs) in vivo systems, one using green fluorescent protein detection of expression, and an E. coli based cell-free in vitro system optimized for MP expression. The protein purification core, aided by several characterization methods, provides pure homogeneous and stable proteins free of excess detergent. The electron microscopy core provides further characterization and 2D crystallization. Structure determination methods include X-ray diffraction and NMR spectroscopy, where cell-free expression has been harnessed to a combinatorial labeling strategy for rapid determination of backbone structures. The X-ray crystallography core provides robotic crystal trials and diffraction at the Advanced Light Source beam line 8.3.1, one of the world's most productive protein crystallography facilities. Overall, the combined expertise of principal investigators provides a unique environment to achieve the proposed aims. PUBLIC HEALTH RELEVANCE: Integral Membrane Proteins account for ~30% of a proteome and play critical roles in metabolic, regulatory and intercellular processes. Human MPs are the targets for ~40% of all therapeutic drugs, but the number of MP structures is less than 0.5% of the number of soluble protein structures. The proposed Center brings together 11 Investigators at five US institutions to focus cooperatively on the overarching aim of determining integral MP structures of high biomedical impact.

Public health relevance
Public Health Relevance Section. Using no more than two or three sentences, describe the relevance of this research to public health. In this section, be succinct and use plain language that can be understood by a general, lay audience (if no changes have been made, please indicate that under the heading 3Modified Public Health Relevance2). a. Please refer to the Guide Announcement for additional information: http://grants.nih.gov/grants/guide/notice-files/not-od-09-088.html 2. In addition, I will also need updated Other Support for Dr. Giacommini (PI for ABC/SLC Transporters). All information must be routed through the UCSF Business Office. Thanks, Jeni Jeni A. Smits Grants Management Specialist 2 NIH/NIGMS 45 Center Drive, MSC 6200 Room 2An.32a Bethesda, MD 20892 T/301-594-3927 & F/301-480-2554 -- Robert M. Stroud http://msg.ucsf.edu/stroud/index.html [email] Phone: s412Office 415 476 4224 FAX 415 476 1902 Suzan Betheil 415 514 4179 UCSF MC2240 S412C UCSF-GENENTECH HALL 600 16th. Street San Francisco California 94158-2517 3 Modified Public Health Relevance Section No changes have been made.) Program Director/Principal Investigator: Stroud, Robert M. (Last, first, middle) For New and Renewal Applications (PHS 398) - DO NOT SUBMIT UNLESS REQUESTED For Non-competing Progress Reports (PHS 2590) - Submit only Active Support for Key Personnel PHS 398/2590 OTHER SUPPORT GIACOMINI, K. ACTIVE 1U19GM61390-11 Parent Grant (Giacomini) 07/01/2010 - 06/30/2015 3.00 calendar NIH/NIGMS $1,500,000 Pharmacogenetics of Membrane Transporters $215,000 to PI The major goals of this project are to screen for genetic variants in membrane transporters and to perform functional screens in cellular assays. R01 GM036780 (Giacomini) 08/01/2007 - 05/31/2011 2.40 calendar NIH/NIGMS $219,000 Cellular Mechanisms of Drug Elimination The major goals of this project are to determine the cellular mechanisms of organic ion transport. The project focuses on organic ion transporters. Gilead Sciences, Inc. (Giacomini) 5/01/2009 - 4/20/2011 0.12 calendar $113,215 K. Giacomini is PI of an industry contract with Gilead, Inc. The goal of the study is to identify genetic factors that increase risk for tenofovir induced kidney toxicity. 17RT-0126 (Giacomini) 07/01/2008 - 06/30/2011 0.96 calendar Tobacco Related Disease Research Program $131,460 Pharmacogenomics of New Generation Platinums in Lung Cancer The goal of our research is to determine the effects of organic cation transporters on the cytotoxicity of oxaliplatin and picoplatin, two newer generation anti-cancer platinum drugs, in lung cancer. U54 GM074929 (Stroud) 07/04/2005 - 06/30/2010 0.36 calendar NIH/NIGMS No Cost Extension to 6/30/11 Specialized Center for the Protein Structure $46,686 The major goals of this project are molecular structures of ABC Transporters. OVERLAP: None PHS 398/2590 (Rev. 06/09) Page ___ Other Support Format Page Program Director/Principal Investigator: Stroud, Robert M. (Last, first, middle) For New and Renewal Applications (PHS 398) - DO NOT SUBMIT UNLESS REQUESTED For Non-competing Progress Reports (PHS 2590) - Submit only Active Support for Key Personnel PHS 398/2590 OTHER SUPPORT GIACOMINI, K. ACTIVE 1U19GM61390-11 Parent Grant (Giacomini) 07/01/2010 - 06/30/2015 3.00 calendar NIH/NIGMS $1,500,000 Pharmacogenetics of Membrane Transporters $215,000 to PI The major goals of this project are to screen for genetic variants in membrane transporters and to perform functional screens in cellular assays. R01 GM036780 (Giacomini) 08/01/2007 - 05/31/2011 2.40 calendar NIH/NIGMS $219,000 Cellular Mechanisms of Drug Elimination The major goals of this project are to determine the cellular mechanisms of organic ion transport. The project focuses on organic ion transporters. Gilead Sciences, Inc. (Giacomini) 5/01/2009 - 4/20/2011 0.12 calendar $113,215 K. Giacomini is PI of an industry contract with Gilead, Inc. The goal of the study is to identify genetic factors that increase risk for tenofovir induced kidney toxicity. 17RT-0126 (Giacomini) 07/01/2008 - 06/30/2011 0.96 calendar Tobacco Related Disease Research Program $131,460 Pharmacogenomics of New Generation Platinums in Lung Cancer The goal of our research is to determine the effects of organic cation transporters on the cytotoxicity of oxaliplatin and picoplatin, two newer generation anti-cancer platinum drugs, in lung cancer. U54 GM074929 (Stroud) 07/04/2005 - 06/30/2010 0.36 calendar NIH/NIGMS No Cost Extension to 6/30/11 Specialized Center for the Protein Structure $46,686 The major goals of this project are molecular structures of ABC Transporters. OVERLAP: None PHS 398/2590 (Rev. 06/09) Page ___ Other Support Format Page